Core E: Invertebrate Longevity and Healthspan

CORE E: INVERTEBRATE LONGEVITY AND HEALTHSPAN – SUMMARY/ABSTRACT
This Core will assist investigators throughout the research community in quantifying a variety of longevity and
healthspan measures in two of the major invertebrate model organisms: the budding yeast Saccharomyces
cerevisiae and the nematode Caenorhabditis elegans. This will be accomplished through direct collaboration,
training and outreach, and the development and dissemination of new tools and technologies. New
technologies we have developed and will disseminate include microfluidic tools for invertebrate aging studies
and the WormBot, a robotic system for high-throughput survival and behavioral phenotyping in C. elegans. We
will also work to develop chemostat-based solutions for obtaining age-matched pure populations of yeast for
biochemical and cell biological experiments requested by Core users. The focus on yeast and worms allows
us to provide services and technologies to a large number of external investigators and thereby have a
correspondingly large impact. The data generated by this Core can be correlated with high dimensional
computational analyses (Core F) and with the protein and metabolite phenotypes studied in Cores C and D,
respectively. Invertebrate models are also highly accessible to junior investigators, and Core B support for pilot
projects allows these investigators access to the full range of integrated services provided by the Center
Resource Cores.